2022 Streptococcal Biology Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
The purpose of this grant submission is to request funds to partially support the 2022 Streptococcal Biology
Gordon Research Conference (GRC) and Gordon Research Seminar (GRS). This will be the second meeting of
this GRC and the first meeting of the GRS, the purpose of which is to foster development of the next generation
of investigators and invite their active participation and integration into the broader research community. Both
meetings will be held the Jordan Hotel at Sunday River, Newry, Maine, USA, with the GRS being held on August
13-14, 2022 and the GRC following on August 14-19, 2022. The Chairs for the 2022 meeting will be Drs. Kelly
Doran and
Shiranee Sriskandan.
Drs.
Michael Federle and Jan-Willem Veening
will serve as Co-Vice Chairs for
the 2022 meeting. Postdoctoral fellow,
Brady Spencer, and graduate student, Lamar Thomas,
will serve as Co-
Chairs of the GRS. The GRS/GRC program encompasses a wide range of exciting topics among important
human and animal pathogens from the genera Streptococcus and Enterococcus. Topics will include genomics,
virulence regulation, phage, host-pathogen interactions, microbial communities and advancing therapeutics.
Additionally, through invited speakers and panelists, the GRS will address current topics in the field of scientific
research spanning as well as scientific communication. The overall goal of the GRC and its associated GRS is
to bring the world's leading scientists and the most promising young investigators and trainees together in a
collegial and supportive environment. The specific goals are to: 1) provide a forum for the presentation of
unpublished, cutting-edge research on streptococci and enterococci and foster formal and informal discussions
on how these results advance the field, 2) include investigators and clinicians focusing on diverse streptococcal
species and define the impact of these on infection 3) expand the boundaries of the work of the scientists within
this field, and 4) ensure development and integration of young investigators, including those in under-
represented groups into the broader research community in a meaningful and interactive way. The collegial
atmosphere will include organized discussion sessions during talks and poster sessions, and opportunities for
informal gatherings in the afternoons and evenings, providing an ideal setting for scientists from different
disciplines to exchange ideas and foster cross-disciplinary collaborations both among themselves and the next
generation of investigators. Thus, the GRC will provide a unique and fundamentally important opportunity to
bring together leading investigators in a format designed for the free exchange of research results and ideas
covering all aspects of streptococcal biology and its relationship to disease. Together with the GRS, the GRC
will promote diversity, equity and inclusion and the development of promising young investigators in the field and
their integration into the larger research community. In the short term, this will significantly enhance the ability of
investigators around the world to address critical problems in streptococcal and enterococcal diseases, while in
the long term it will ensure the continued success of their efforts and those of the next generation of investigators.

Public health relevance
NARRATIVE We seek NIH support for a diverse cohort of graduate students, postdocs, and early career scientists to attend the 2022 Streptococcal Biology Gordon Research Conference (GRC) and the Inaugural Gordon Research Seminar (GRS). The GRC/GRS will significantly improve scientific knowledge in all areas of streptococcal and enterococcal disease including diagnosis, epidemiology, pathogenesis, and treatment, by bringing together the most talented and productive researchers in the field and facilitating their interactions with the next generation of scientists and clinicians.